Phagineering the gut microbiome: Bacteriophages to reduce Desulfovibrio spp. and hydrogen sulfide in the intestine

Project Summary
The excessive production of hydrogen sulfide (H2S) gas has been implicated in a number of health conditions including
ulcerative colitis, Crohn’s disease, and colon rectal cancer due to its toxicity and inflammatory properties. While these
associations have not been shown to be definitively causative, one well known fact about intestinal H2S experienced by all
is its contribution to malodorous flatulence. Flatus is composed of numerous odorless gases, but primarily the presence of
H2S, characterized by its sulfurous “rotten egg” aroma, provides the foul odor of flatus. For those individuals with
frequent excessively odorous flatulence, it can be a debilitating and embarrassing condition. While the human body
produces its own endogenous H2S, a large fraction of the exogenous H2S produced in the intestine comes from the
microbiome, specifically from the sulfate-reducing bacteria (SRB). SRB utilize sulfate as their terminal electron acceptor
leading to the production of the foul-smelling and toxic H2S within the gut. Of the SRB, the most predominant in the
human gut are members of the genus Desulfovibrio. Sulfur-rich diets such as meat, cheese, and processed food provide
fuel for SRB metabolism, and, as such, dietary protein is positively correlated with H2S production in the intestine. Due to
these connections between dietary sulfur, SRB, H2S, and malodorous flatus, it is probable that a targeted reduction of
Desulfovibrio spp. in the gut may lead to reduced levels of H2S and thereby less offensive odorous flatulence. A suitable
form of therapy is required for this modulation: classical antibiotics are ill suited to this task as their broad-spectrum is
likely to disrupt the commensal microbiota. Bacteriophages (phages) are uniquely suited to targeted modulation of the
intestinal microbiome; they are natural predators of bacteria and highly specific to their hosts. This project proposes the
development of natural prebiotic bacteriophage cocktail for the targeted reduction Desulfovibrio to promote overall health
and well-being of the intestine, as well as reduce the malodorous scent of flatulence and its associated embarrassment. To
this end, a panel of human associated Desulfovibrio isolates will be assembled. “Phage hunts” for phages infecting
Desulfovibrio spp. will then be performed using methods developed as part of preliminary data generation. Isolated
phages will be characterized, formulated into cocktails, and cocktail host range expanded through directed evolution. This
project will be led by Dr. Justin Boeckman who will pursue a number of training courses to enhance his business acumen
during the project duration. Dr. Boeckman will also be advised by valuable mentorship of Dr. Jason Gill (Technical
Mentor – Texas A&M) and Dr. Neema Mayhugh (Business development- Wave Strategy) to ensure this project succeeds
both on a technical and career development level.

Public health relevance
Project Narrative The proposed research has the potential to develop a novel prebiotic bacteriophage cocktail product aimed at a targeted reduction in Desulfovibrio spp. from the human intestine. By reducing the carriage of Desulfovibrio from the intestine, it is expected that a reduction in deleterious and malodorous hydrogen sulfide (H2S) gas will be achieved. Through this reduction in hydrogen sulfide gas, we aim to promote overall health and wellbeing, a reduction in malodorous flatulence and its associated stigma, as well as potential alleviation of emerging disease states being linked to excessive H2S gas.